PARKINSON'S DISEASE

Determine whether transplantation of adrenal medullary tissue to the caudate nucleus will have a therapeutic effect on the motor symptoms and signs of Parkinsonism and its rate of progression in patients with Parkinson Disease.